Hispanic/Latinxs coexisting chronic health conditions, mental illness and social determinants of health

Project Summary. People with mental illness (MI) die an average of 20 years earlier than the general population
due to coexisting chronic health conditions (CHC, i.e., cancer, heart disease, diabetes). Hispanics/Latinxs (H/L)
are a particularly vulnerable ethnic group in the United States (US), accounting for higher rates of MI and chronic
health conditions than other minority ethnic groups. Specifically, H/L with MI have higher rates of obesity, and
other metabolic risk factors placing them at elevated risk for cancer, heart disease, and diabetes. However,
despite this alarming scenario, no research to date has established the prevalence of co-existing health
conditions among H/L living with MI in the US. Furthermore, limited attention has been paid to how the interplay
between multiple domains (i.e., biological, physical environment, sociocultural) and levels of influence (i.e.,
individual, interpersonal) drive these disparities among H/L with MI in the US. There is some evidence on how
social determinants of health (SDH; i.e., gender, age, discrimination) correlate with poor health outcomes.
However, it remains unclear how these SDH contribute to the health disparity burden experienced by H/L with
MI in the US; which in turn, limits the availability of effective resources to improve their health. The overall goal
of this proposal is to assess the contribution of social determinants of health, genetic ancestry and mental
conditions in the prevalence, progression, and outcomes of coexisting chronic diseases in H/L. The central
hypothesis is that H/L history of mental health diagnosis and adverse social contexts are co-occurring health risk
factors and predictor in coexisting chronic health conditions. The All of Us Research Program datasets provide
a unique opportunity to better understand the health disparities experienced by H/L with MI in the US. The aims
of the proposed study are: Aim 1: Determine the prevalence of coexisting chronic health conditions (i.e., cancer,
heart disease, diabetes) among H/L with a history of a mental illness diagnosis versus Hispanic/Latinxs without
a history of a MI diagnosis. Aim 2: Determine the role of social determinants of health in the prevalence of
coexisting chronic health conditions H/L with a history of a mental illness diagnosis.

Public health relevance
Project Narrative. The objective of this administrative supplement is to assess the contribution of social determinants of health, genetic ancestry and mental conditions in the prevalence, progression, and outcomes of coexisting chronic diseases in Hispanic/Latinx (H/L). The parent grant (5U54MD007579-36) goal is to contribute to the improvement of minority health, prevent, and eliminate health disparities. Using this All of us database, this supplement is expected to contribute to the parent study’s goal of eliminating health disparities by addressing research gaps in the health disparities research literature among H/L such as the respective contribution of social and biological or ancestral factors at the intersection of mental illness and chronic conditions.